Translational Platform for Epilepsy Therapy and Biomarker Discovery

PROJECT SUMMARY
There is currently no validated treatment to prevent the development of acquired epilepsies, such as post-
traumatic epilepsy. The availability of biomarker that predicts, at an early stage, people at risk to develop epilepsy
and benefit from treatment interventions would significantly accelerate and de-risk the process of identifying an
antiepileptogenic therapy. In this study, that is based on collaborations and preliminary data derived from
EpiBioS4Rx, an NINDS funded Center without Walls, we aim to create a rigorous and effective preclinical model
to screen a new candidate treatment to prevent posttraumatic epilepsy in the lateral fluid percussion injury model
as well as identify biomarkers to guide treatment implementation. We will follow a multicenter, double-blinded,
vehicle-controlled, randomized preclinical antiepileptogenesis study following the high standards of rigor
advocated by NINDS, the AES/ILAE Translational Research Task Force and the ARRIVE guidelines. We have
formed a collaborative group of four international preclinical testing centers (Albert Einstein College of Medicine,
University of Melbourne, two UCLA sites), supported by experts in pharmacokinetic modeling (University of
Minnesota), protein biomarker research (Uniformed Services University of the Health Services) and
bioinformatics (University of Southern California). We plan to test a compound that removes pathological iron
stores from the brain and test whether it can modify early biomarkers of epileptogenesis and injury. We aim to
identify (a) at least one panel of multimodal biomarkers that can predict early on treatment response to the iron
chelator, including the development of post-traumatic epileptogenesis, (b) at least one biomarker of
epileptogenesis, (c) and determine whether iron chelator treatment can prevent post-traumatic epilepsy
development.

Public health relevance
PROJECT NARRATIVE There is currently no therapy that can prevent the development of epilepsy after brain trauma. Here we propose to test the efficacy of a novel compound, and determine its efficacy and tolerability in an animal model of posttraumatic epilepsy, in a setting that resembles the clinical practice of care of people with severe traumatic brain injury. We also aim to identify and validate novel biomarkers that can predict who will develop epilepsy and who may respond to a treatment that can prevent epilepsy, in hope that this may accelerate and optimize future efforts to develop new antiepileptogenic therapies.